Pilot-Trans Network Core

Project Summary - Pilot Projects and Trans-Network Activities Core D
The overall goals of the Pilot Core are to advance high-quality research, foster new ideas for the PDX
Development and Trial Center and the PDXNet in order to strengthen the foundation of ongoing studies in the
projects, and to interact with investigators inside and outside of the PDTC. To accomplish these goals, two
specific aims are proposed:
Aim 1: To attract, select, and fund the most outstanding proposals with significant potential to benefit the
PDTC and the PDXNet.
Aim 2: To support and integrate the selected pilot projects into the PDTC program with established processes
to review and monitor progress.
Women and underrepresented minorities will be strongly encouraged to participate. The Pilot Core has a
transparent peer-reviewed selection process that incorporates defined criteria for funding decisions.
We will require that Pilot Project awardees be active in PDTC functions, use the PDTC and core resources,
and provide formal written progress reports. Within the context of the core, we have established high standards
and expectations of the investigators and have established a formal process to review and monitor progress of
funded pilot projects. The program measures success by resulting publications, resulting funding, stimulating
new aims in existing PDTC projects, and strengthening the resources, technologies, and approaches within the
PDTC and PDXNet.